Molecular pharmacology and physiology of kidney potassium transport

DESCRIPTION (provided by applicant): Inwardly rectifying potassium (Kir) channels are key regulators of diverse physiological processes and may represent novel drug targets for diseases. Their therapeutic potential has not been tested directly, however, due to the lack of drug-like compounds targeting inward rectifiers. The lack of selective probes has also hindered efforts to define the physiological functions of some Kir channels. To overcome this formidable barrier and create new opportunities for studying inward rectifier physiology, the investigators performed a high- throughput screen (HTS) of more than 200,000 compounds for small-molecule modulators of ROMK (Kir1.1), a putative target for a novel class of diuretic. One compound, termed VU590, inhibits ROMK at nanomolar concentrations and Kir7.1 in the low micromolar range, making it the first small-molecule inhibitor of both channels. The investigators went on to use medicinal chemistry to rationally design a nanomolar-affinity probe, termed VU591, which is highly selective for ROMK over more than 60 potential off targets, including inward rectifiers and BK channels. In Aim 1, the investigators will employ state-of-the-art molecular modeling techniques, atomic structure-guided mutagenesis and electrophysiology to define the VU590/591 binding sites in ROMK and Kir7.1. VU591 is remarkably selective for ROMK and therefore represents a promising candidate for further development for use in animal studies. In Aim 2, the investigators will first determine if VU591 is active in the native tissue by assessing its effects on K and Na transport in isolated perfused cortical collecting ducts under low- and high-flow conditions. The investigators also discovered a nanomolar-affinity inhibitor of a G-protein regulated inward rectifier (GIRK), a putative therapeutic target for atrial fibrillation. In Aim 3, the investigators will use medicinal chemistry, structure-guided mutagenesis and electrophysiology to define the molecular binding sites for this novel compound termed VU592. These studies will provide important new insights into the atomic structures of inward rectifiers and generate critically needed probes with which to define the integrative physiology and therapeutic potential of these channels. Lay summary: The investigators will combine medicinal chemistry, advanced computational techniques and classical physiological methods to develop drug-like compounds targeting potassium channels that could be therapeutic targets for hypertension, edema and cardiac arrhythmia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Inward rectifying potassium (Kir) channels play key physiological roles in diverse cellular functions and may represent novel drug targets. However, the lack of selective pharmacological "probes" has hindered efforts to explore the integrative physiology and therapeutic potential of most Kir channels. Here we propose to employ medicinal chemistry, atomic structure-guided mutagenesis, kidney tubule microperfusion and electrophysiology to develop the small-molecule pharmacology for Kir1.1, Kir7.1 and Kir3 channels. NARRATIVE Inward rectifying potassium (Kir) channels play key physiological roles in diverse cellular functions and may represent novel drug targets. However, the lack of selective pharmacological "probes" has hindered efforts to explore the integrative physiology and therapeutic potential of most Kir channels. Here we propose to employ medicinal chemistry, atomic structure-guided mutagenesis, kidney tubule microperfusion and electrophysiology to develop the small-molecule pharmacology for Kir1.1, Kir7.1 and Kir3 channels. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Inwardly rectifying potassium (Kir) channels play key physiological roles in diverse cell types and could be novel drug targets for hypertension, edema and arrhythmias. Their therapeutic potential has not been tested directly, however, due to the lack of drug-like compounds targeting Kir channels. The dearth of selective pharmacological "probes" has also hindered efforts to understand the integrative physiology of most inward rectifiers. To overcome this formidable and long-standing barrier and create new opportunities for studying inward rectifier physiology, we performed a high-throughput screen of more than 200,000 compounds for small-molecule modulators of ROMK (Kir1.1), a postulated target for a novel class of diuretic. The screen and follow-up studies have been very successful. In the revised application, we propose a series of focused, hypothesis-driven experiments that will combine medicinal chemistry, atomic structure-guided mutagenesis and electrophysiology to develop and utilize small-molecule probes to reveal novel insights into Kir channel structure, molecular pharmacology and physiology. The specific aims of the proposal are as follows: Aim 1. Test the hypothesis that the VU590/591 binding sites are distinct in ROMK and Kir7.1. The first small-molecule inhibitors of ROMK were identified in our screen. One compound, termed VU590, inhibits ROMK at nanomolar concentrations and Kir7.1 at low micromolar concentrations, making it the first small- molecule inhibitor of both channels (Lewis et al., 2009). More recently, we have employed medicinal chemistry to rationally design a nanomolar-affinity ROMK inhibitor, termed VU591, which is highly selective for ROMK over inward rectifiers, Slo1/β1 BK channels and more than 60 other potential off-targets, including voltage- gated sodium, calcium and potassium channels. VU590 and VU591 are structural analogs, but VU591 does not block Kir7.1. Patch clamp experiments suggest that both compounds bind in the intracellular pore of ROMK. We hypothesize that the amino acids comprising the VU590/591 binding sites occupy the same general pore location, but are only partially conserved between the two channels. In Aim 1, we will test this hypothesis directly using atomic structure-guided mutagenesis and electrophysiology to define the location and atomic features of the VU590/591 binding sites in ROMK and Kir7.1. Aim 2. Test the hypothesis that VU591 inhibits cation transport in the distal nephron. We are working to develop small molecules that can be used to probe the physiological responses to pharmacological ROMK inhibition in vivo. VU591 is a promising lead compound, but we do not yet know if it will inhibit native ROMK activity in the nephron. Furthermore, a decisive factor in determining if ROMK is a viable therapeutic target is whether channel antagonists will limit K secretion during diuresis. In Aim 2, the effects of VU591 on basal and flow-stimulated K and Na transport will be determined in microperfused collecting ducts. Aim 3. Define the selectivity, structure-activity relationships and molecular binding sites of the GIRK channel inhibitor VU592. We assembled from the primary screen a focus library of approximately 300 weak ROMK inhibitors to be screened for modulators of other inward rectifiers. In the first counterscreen, we discovered several micromolar-affinity ROMK inhibitors that blocked Kir3.1/3.2 (GIRK) channels at nanomolar concentrations. GIRK channels are critical regulators of cardiac and nervous system function and are a potential therapeutic target for atrial fibrillation. In Aim 3, we will employ combinatorial chemistry, structure- guided mutagenesis and electrophysiology to develop one GIRK inhibitor termed VU592. These studies will produce a novel GIRK channel antagonist of defined potency and selectivity that will then be used to probe the molecular architecture of this critically important channel.